Thyroid Derived Peptide Presentation by HLA-DR in Thyroiditis

Autoimmune thyroid diseases (AITD), including Graves' disease (GD) and Hashimoto's thyroiditis (HT) are
currently treated only symptomatically and not by targeting the mechanisms causing disease. Our long-term
goal is to design precision-targeted therapies for AITD by blocking presentation of thyroidal antigens to T-cells.
In order to block antigen presentation we are targeting HLA-DRb1-Arg74, which we have previously shown to
be the key HLA-DR pocket that presents thyroidal peptides triggering AITD. During the last grant period we
made significant progress towards our long-term goals: (1) We identified the key TSHR peptide epitope
causing GD; (2) We identified Cepharanthine as a compound that blocks DRb1-Arg74 and prevents AITD in a
mouse model; (3) We identified D-peptides that block peptide binding to DRb1-Arg74; (4) Using genome-wide
approaches we identified new AITD susceptibility genes (e.g. ARID5B); (5) We identified genetic-epigenetic
interactions triggering AITD. Building on the progress made in the previous grant period we propose to develop
new therapeutic approaches for AITD by blocking antigen presentation. Our hypothesis is that presentation of
pathogenic Tg/TSHR peptides to T-cells within the DRb1-Arg74 pocket we discovered is key to triggering
AITD, & that blocking peptide binding to this pocket can be used to treat/prevent AITD. Our specific aims are:
Specific Aim 1: We will enhance the potency and efficacy of Cepharanthine in blocking antigen presentation
within DRb1-Arg74 by creating modified Cepharanthine analogs (MCA's). We will use in silico methods to
design MCA's; MCA's will be confirmed using our uniquely designed ELISA and cell based assays, and using
ex vivo and in vivo experiments in “humanized” DR3 mice in which we will induce autoimmune thyroiditis.
Specific Aim 2: We will generate monoclonal antibodies (MAb's) targeting the HLA-DRb1-Arg74 – Tg.2098
complex. This approach is based on our findings that presentation of the Tg peptide Tg.2098 by DRb1-Arg74 is
the key step in triggering AITD. The MAb's we produce will be screened by our in vitro ELISA and cell based
assays, and confirmed ex vivo and in vivo in our DR3 “humanized” mouse model of AITD.
Specific Aim 3: We will validate that MCA's & MAb's block antigen presentation in patients with AITD. We will
validate MCA's and MAb's by testing their ability to inhibit T cell recall responses to thyroidal antigens in
peripheral blood mononuclear cells (PBMC's) isolated from AITD patients that are positive for DRb1-Arg74.
In summary, our multidisciplinary translational project builds on the knowledge gained in the previous grant
period. Our goal is to pursue preclinical development of novel therapies for AITD based on blocking antigen
presentation by HLA-DRb1-Arg74. Our collaborative team has the capacity, experience, & expertise to achieve
the aims of our proposal. The main advantage of our therapeutic approach is that it is both selective since only
T-cells recognizing pathogenic thyroidal peptides are targeted and personalized since only patients carrying
the HLA-DRb1-Arg74 will be treated. Our translational studies will hopefully lead to novel therapies for AITD.

Public health relevance
PROJECT NARRATIVE Autoimmune thyroid diseases (AITD) include Graves' disease (GD) and Hashimoto's thyroiditis (HT). Currently there are no specific targeted therapies for AITD, and patients are treated symptomatically by hormone replacement in HT and hormone suppression in GD. The overall goal of our studies is to dissect the mechanisms causing AITD, and to use this knowledge to develop new therapies for these disorders.